Novel Mechanisms of Catalysis in Natural Product Biosynthesis

ABSTRACT
Natural products offer a rich and plentiful source of novel compounds with biological activities from which fresh
inspiration can be drawn for the discovery and design of new pharmaceuticals. Moreover, the rapid pace at which
bioinformatic and genomic technologies are developing has led to a wealth of untested leads and intriguing
questions regarding the biosynthetic pathways for these compounds. Enzymes utilizing radical intermediates are
featured prominently here catalyzing chemical transformations that would otherwise not be possible under
physiological conditions. Consequently, secondary metabolism is characterized by a multitude of unusual
chemical structures rarely observed in primary metabolism. However, the instability of free radicals can easily
lead such enzymatic reactions to go awry due to even minor perturbations. Not only does this suggest a
mechanism for the evolution and diversification of radical-mediated transformations as proposed for radical SAM
(S-adenosyl-L-methionine) enzymes but also implies that these enzymes may be engineered to catalyze similarly
challenging transformations with applications in synthetic biology. In the spirit of helping to realize this potential,
we have identified two primary areas of investigation with additional exploratory worked planned as well. The
first direction involves study of the homologous pair of dehydratase and dehydrogenase twitch radical SAM
enzymes BlsE and HikC, which respectively participate in the biosynthesis of the fungicide blasticidin S and
antihelminthic agent hikizimycin. Given their evolutionary relationship, we hope to tease apart their catalytic
properties in a comparative manner in order to understand how the fates of their radical intermediates are
channeled to effect two distinctly different catalytic outcomes. The second direction focuses on biosynthesis of
the antiviral nucleosides oxetanocin A and albucidin. Where one would normally expect a ribose, these natural
products instead possess a four-membered oxetane ring that is constructed via radical-mediated transformations
catalyzed by B12-dependent radical SAM enzymes. This chemistry is thus unique among the cobalamin-
dependent radical SAM enzymes, which are primarily known to function as methyltransferases. These two
projects are not only designed to offer new insights into the mechanisms of secondary metabolic enzymes that
utilize radical intermediates but also to open new avenues of study. Nevertheless, a third component of the
proposal is specifically designed to probe high risk systems including biosynthesis of the cis-fused cyclobutane
ring system of ladderanes; a non-heme iron enzyme with a unique quadruple-histidyl/carboxylysyl coordination
sphere newly discovered in the biosynthesis of oxazinomycin; as well as a radical SAM enzyme that catalyzes
an unusual sulfur-for-oxygen bridge swapping reaction during biosynthesis of the Trojan horse antibiotic
albomycin. Collectively our efforts are intended to provide a solid and principled foundation on which chemical
biologists and biotechnologists can ground their own research and discovery efforts for the betterment of human
health and wellbeing.

Public health relevance
Project Narrative Our research program continues in the tradition of exploring the enzymes and pathways of secondary metabolism and natural product biosynthesis for novel chemistry that may be of value for the betterment of human health and well-being. A particular emphasis is placed on the detailed mechanisms and evolution of radical-mediated chemical reactions leading to structurally unique antiviral (oxetanocin A and albucidin), antifungal (blasticidin S) and antihelminthic agents (hikizimycin) as well as the biosynthesis of high energy (ladderane) and antibacterial agents (oxazinomycin and albomycin). By investigating these and similar systems, we aim to establish the fundamental chemical principles by which these reactions occur and in particular how highly reactive radical intermediates are guided towards biochemically useful compounds.